Nutritional Quality of Breast Milk after 6 Months Postpartum in India

PROJECT SUMMARY
Breast milk is a critical component of infant and young child nutrition in the first 1,000 days of life and has well-
established benefits for mother and child. The complementary feeding period involves the transition from
exclusive breastfeeding to partial/continued breastfeeding along with gradual introduction of complementary
foods. During this time, the child is at increased risk for dietary and growth deficits, which are often due to poor
complementary feeding practices and lack of evidence regarding maternal breast milk composition. Furthermore,
the extent to which breast milk composition and quality can be modulated through maternal dietary interventions
remains unclear. Interventions to date have mainly focused on breast milk composition during the first six months
postpartum or analyzed single nutrients or nutrient groups. A comprehensive assessment of micro- and
macronutrient contents in breast milk after 6 months postpartum, while breastfeeding is still ongoing, and its
longitudinal change in response to a dietary intervention has, to our knowledge, never been conducted.
To accomplish this, we will study breast milk samples from a subset of breastfeeding mothers who are
participating in a randomized controlled feeding trial comparing the efficacy of biofortified versus conventional
crop consumption in mothers and children in South India. We have collected and archived breast milk samples
at five different timepoints across nine months during the child’s complementary feeding period. The objective of
the proposed research is to increase our understanding of breast milk quality during the complementary feeding
period. We aim to close the current evidence gap with two Specific Aims. (1) We will determine and describe the
micro- and macronutrient composition of breast milk after 6 months postpartum; (2) We will also determine the
impact of a nutrition intervention on breast milk composition with longitudinal samples collected during follow-up
in a randomized controlled feeding trial. The proposed analysis will provide unique insights into the relationship
between maternal nutritional status and breast milk composition in the complementary feeding period. Through
this proposed research we aim to lay the foundation for future studies aiming to enhance breast milk
quality to both improve the nutritional status of and lower the associated risk for adverse events and morbidity
in children.
1

Public health relevance
PROJECT NARRATIVE The complementary feeding period is critical for a child’s proper development, but evidence regarding breast milk composition during this time and the extent to which the maternal diet can alter its composition is scarce. We aim to describe the micro- and macronutrient composition of breast milk after 6 months postpartum and potential longitudinal changes of breast milk composition in response to a dietary intervention consumed by mothers. We will assess micro- and macronutrient contents in archived breast milk samples that were collected at different timepoints as part of a randomized controlled feeding trial in mothers and their children in South India. 2